Microchemistry and Proteomics

ABSTRACT
The Microchemistry and Proteomics (MCP) Core provides mass spectrometric sequencing and quantitation
of peptides and proteins to support basic, translational, and clinical research programs at MSK. The Core
utilizes modern high-resolution mass spectrometry and nanoscale liquid chromatography in conjuction with
biochemical processing of samples with the end goal of determining the identity, relative abundance, and
presence of post translational modifications from purified components, cell lysates, tissues, and select fluid
such as cerebral spinal fluid. Proteins and post translational modification are critical components of complex
signaling pathways underlying development, cell growth, differentiation, DNA repair, senescence, immune
response to cancer, and response to bioactive therapies. Dissection of these pathways can lead to insights on
the underlying molecular mechanisms involved in cancer. The goal of the MCP Core is to be an efficient, user
friendly, state-of-the-art facility. Advice is provided by the Core staff to facilitate the design, execution, and
analysis of experiments. Over the past year, the Core has supported research from 38 investigators. Over the
past grant period, investigators from all 10 programs have been supported, and the Core has contributed to
207 publications.